Tissue Engineering and Cell Models (TECM)

PROJECT SUMMARY/ABSTRACT
The Tissue Engineering and Cell Models Core (TECM) enables Universtiy of Chicago (UChicago) Digestive
Diseases Research Core Center (DDRCC) for Interdisciplinary Study of Inflammatory Intestinal Disorders (C-
IID) investigators to address key questions relating to causality and mechanisms by providing novel and vetted
experimental models that can be customized to their needs. It was established to replace the Genomics and
Molecular Engineering (GME) Core of the C-IID. The reorganization of the Core was a direct result of two
sequential annual needs assessments indicating strong interest by the membership for more physiologically-
relevant experimental models to study digestive health and diseases. The TECM has three major components:
(1) A centralized repository and facility for established and primary gut-relevant cell lines, which was originally
part of the host-microbe core, but moved to the TECM to centralize all cell and tissue experimental systems,
(2) A tissue engineering component that includes customizing and developing intestinal organoid technologies
for specific applications needed by C-IID users, and (3) an experimental systems component that includes in
vivo models (rodent microsurgery), ex vivo models, and live functional assays. Inherent to these services, the
TECM provides training and education, opportunities for cost-savings through bulk purchases (serum,
disposables, etc), and technical expertise that saves investigators time and ensure high quality of services.
The TECM is inextricably tied to the other C-IID cores. The Integrative Clinical and Biospecimen (ICB) and the
Host-Microbe (HM) cores are essential for providing cells, tissues, and patient samples for establishing the
experimental models. The Multiparametric Host Cell Analysis (MHC) core provides investigators with the
means to analyze data derived from the model systems. Thus, the TECM Core has had great impact in
enabling C-IID members to advance knowledge in the thematic areas fostered by the C-IID which focus on the
study of IBD, host-microbe interactions, mucosal immunology and inflammation. In the past funding cycle, it
was used by ~80% of the C-IID membership and was used in 149 peer-reviewed publications or 46% of the
total (322) C-IID acknowledged publications during this period. The TECM has promoted interaction,
collaboration, cost-sharing, and efficient resources utilization, and, at the same time, has enhanced the
capabilities of our investigators.